Enrichment Program

PROJECT SUMMARY/ABSTRACT
Please refer to the Project Summary/Abstract in the OVERALL section of the application.

Public health relevance
PROJECT NARRATIVE Please refer to the Project Narrative in the OVERALL section of the application.